Informatics Research Core

Our overall mission is to produce data-driven decisions and accelerate efforts across the entire spectrum of translational research by developing novel or using existing informatics approaches. Our efforts span three general areas: 1) translational data analytics: development of custom workflows to interpret complex datasets such as multi-omic and clinical data; 2) standards, knowledge sources, and software: connecting and supporting analyses of various types of experimental and curated datasets; in-house curation efforts; 3) scientific computing and research support: development, maintenance, and deployment of workflows, web and mobile apps to disseminate our robust methods and data. The three general areas are highly synergistic, where work one area informs work in other areas.